Defining Novel Mechanisms of Genome Instability in BRAF-mutant Melanoma

ABSTRACT
In over 50% of cases, activating mutations in the serine/threonine kinase BRAF are found to drive melanoma,
the deadliest form of skin cancer. Canonically, oncogenic BRAF has been shown to promote unrestrained
cellular proliferation by hyper-activating the MAPK signaling pathway. However, whether oncogenic BRAF
promotes additional cellular defects that facilitate tumorigenesis remains relatively unexplored. Utilizing high-
resolution fixed and live-cell imaging, coupled with in vivo zebrafish models, we have observed that expression
of oncogenic BRAF severely impairs chromosome segregation, promotes cytokinesis failure and disrupts
nuclear morphology. The primary objective of this proposal is to identify the underlying mechanisms by which
oncogenic BRAF promotes these cellular defects. In Aim 1, we will define the mitotic defects imparted by
oncogenic BRAF that disrupt normal chromosome segregation. In addition, we will use SILAC mass
spectrometry to test the novel hypothesis that indiscriminant phosphorylation of key mitotic regulators by
oncogenic BRAF underlies the generation of these observed mitotic defects. In Aim 2, we will test the
hypothesis that oncogenic BRAF disrupts normal actin cytoskeletal contractility and/or inappropriately
phosphorylates the nuclear lamina, thus promoting nuclear envelope rupture and the acquisition of DNA
damage. In Aim 3, we will test the hypothesis that the Hippo tumor suppressor pathway, which limits the
proliferation of spontaneously arising tetraploid cells, becomes activated secondary to oncogenic BRAF-
induced cytokinesis failure. Hippo pathway activation will be explored both in vitro, following doxycycline-
inducible expression of oncogenic BRAF in primary cell lines, and in vivo, in human and mouse primary tissue
sections of benign nevi generated by oncogenic BRAF expression. We will also test the hypothesis that Hippo
pathway inactivation restores proliferative ability to BRAF-generated tetraploid cells and thus may facilitate
tumorigenesis. Collectively, these experiments will define novel roles of oncogenic BRAF in driving genome
instability and promoting melanomagenesis.

Public health relevance
NARRATIVE Melanoma is one of the most common cancers in young adults and a leading cancer in terms of average years of life lost per death from disease. Decades of research into melanomagenesis demonstrated that the main driver mutation in over half of melanomas is oncogenic BRAF, which hyper-activates the MAPK signaling pathway and pushes terminally differentiated melanocytes towards uncontrolled cell proliferation. This proposal aims to test the novel hypothesis that oncogenic BRAF plays additional, non-canonical roles in driving tumorigenesis by directly promoting genome instability.